CTSA Postdoctoral T32 at University of Minnesota

ABSTRACT
The mission of the Clinical and Translational Science Institute (CTSI) postdoctoral T32 Program is to contribute
to the nation’s biomedical workforce by training a diverse pool of scientists in clinical and translational science
(CTS) and leadership. We will meet this mission by developing, implementing, and continually improving a
training program for postdoctoral trainees (Scholars) that integrates a mentored research experience with an
individualized curriculum combined with professional development activities highlighting our institutional
strengths in community engagement, data science, team science and effective communication skills. The UMN
CTSI T32 Program is built upon our current successful Translational Research and Career Development
(TRACT) TL1 Program, which guided the development of early-stage CTS researchers over the past 4 years.
Through personalized mentorship, coursework, seminars, and other tools, the TRACT program has guided 6
postdoctoral Scholars along a rigorous path of professional development in CTS. Moving forward, the new
UMN CTSI T32 Program’s mission is to educate and train a diverse group of Scholars from across the UMN
system in the fundamentals of CTS through a 2-year comprehensive yet individualized program. We will recruit
and train 3 diverse (in discipline and underrepresented populations) cohorts of 4 postdoctoral Scholars from
across UMN. UMN CTSI T32 will provide a research experience with mentors trained in evidence-based
mentoring, focusing on collaboration and communication with community members throughout the research
process, inclusive of a Community Mentor and team science across the UMN ecosystem. The UMN CTSI T32
will also include near-peer learning experiences with other CTSI program Scholars as well as provide
education and opportunities for a variety of career paths. The UMN CTSI T32 will use a comprehensive and
adaptive evaluation plan for rigorous programmatic assessment and continuous quality improvement to
maximize the training experience. The principal Scholar outcome is to have a deep knowledge in the science
of translation beyond translational research. Another key Scholar outcome is an understanding of the
importance of, and key strategies for, building truly collaborative interdisciplinary teams composed of people
from diverse backgrounds and experiences whose collective roles synergistically optimize the advancement of
diagnostics, therapeutics, clinical interventions, and behavioral modifications that improve health. Other
outcome measures include the ability to communicate with other scientists and nonscientific audiences and
collaborators through our intensive formalized training in communicating science, and the ability to effectively
engage with communities through intensive community engagement training including a Community Mentor
Program. Programmatic outcomes include the development of training modules and workshops on the most
effective community engagement and communications strategies exportable to the national CTSA consortium.

Public health relevance
UMN Postdoctoral Narrative The Clinical and Translational Science Institute (CTSI) postdoctoral program trains the next generation of scientists to speed application of scientific discoveries to improve human health. Scholars will participate in 2 years of mentored research, individualized curriculum, and professional development activities highlighting our institutional strengths in leadership, community engagement, data science, team science and effective communication skills.